Artificial Intelligence-Based Methods to Characterize Kidney Macrostructure from Pre- and Post-Nephrectomy Computed Tomography Images

PROJECT SUMMARY/ABSTRACT
The prevalence and burden of chronic kidney disease (CKD) is increasing worldwide. Patients who undergo
radical or partial nephrectomy for kidney cancer resemble the general population with comorbidities, but with
the difference that a majority undergo pre- and post-surgery abdominal imaging. Despite successful surgical
tumor removal, there is a concern for future progressive CKD. Following nephrectomy, the unaffected kidney
undergoes compensatory hypertrophy, and the degree of hypertrophy and kidney function decline depend on
the comorbidity burden and the amount of the removed kidney tissue. With the recent advances in artificial
intelligence (AI)--based quantification of kidney volumes from CT scans, there is an opportunity to evaluate
automated imaging biomarkers as prognostic tools. There are also algorithms that quantify the number and
volume of simple parenchymal cysts and many radiomic/texture features. The Co-Principal Investigators in this
program are uniquely equipped for the proposed studies. Dr. Denic has expertise in kidney micro- and macro-
anatomy and advanced biostatistical skills. Dr. Kline has expertise in AI and developing advanced image
processing techniques. The central hypothesis of this proposal is that macrostructural findings on
imaging of the retained (non-operated) kidney after radical or partial nephrectomy are prognostic for
progressive CKD. In Aim 1, we will determine whether the degree of compensatory hypertrophy in the
retained kidney after nephrectomy predicts progressive CKD. Using a recently created deep learning algorithm
we developed, we will quantify the kidney, cortex, and medullary volumes in pre-surgery and follow-up CT
scans (at median 1-year post-surgery). From these volumes, we will calculate the degree of compensatory
changes in kidney volumes and assess their association with baseline comorbidities and microstructural
measures. Finally, we will develop models to predict progressive CKD. In Aim 2, we will first optimize and
finalize training of the model to quantify cysts and their size in CT images and develop postprocessing steps to
separate cortical from medullary cysts. We will then develop models to assess whether the number and size of
cysts (overall, cortical, medullary) in the retained kidney in pre-surgery scans, and changes in number and size
of cysts (overall, cortical, medullary) in the retained kidney over 1-year post-surgery, can predict progressive
CKD. In Aim 3, we will determine whether novel radiological imaging texture features on pre-surgery scans are
reflective of microstructural measures of nephron size and nephrosclerosis and whether kidney texture
features on follow-up CT scans predict progressive CKD. This research program will be facilitated by Mayo
Clinic’s outstanding clinical and research environment at all three sites dedicated to improving patient care.
The goal is to develop a tool that can guide clinical decision-making in everyday practice, and that can help
clinicians in improving their care of patients at an individual level by assessing the future risk of CKD.

Public health relevance
PROJECT NARRATIVE/LAY SUMMARY Chronic kidney disease is a common diagnosis in the general community but also represents a concern in patients who undergo radical or partial nephrectomy for renal cancer. This research program will develop and employ deep learning algorithms to study macrostructural features of non-cancerous kidney tissue. The goals are to establish automated imaging biomarkers as tools that can aid clinicians in predicting the future development of chronic kidney disease and understanding their microstructural histology determinants (nephron hypertrophy and nephrosclerosis).